2023 Elastin, Elastic Fibers and Microfibrils Gordon Research Conference and Gordon Research Seminar

Project Summary/Abstract
Elastin, elastic fibers, and associated microfibrils are particularly abundant in arteries, ligaments, lungs, and skin
but are also important in the tendons, eyes, and bone. Elastin is one of the longest-lived proteins in humans. It
is deposited and cross-linked during development and growth, and then it remains metabolically stable over a
lifetime. Elastin fibers are unique because they provide resilience to dynamic tissues but also elasticity, i.e., they
deform under physiological forces and subsequently release stored energy to drive passive recoil. This
conference will provide in-depth coverage of elastic tissue biology and will include the following: molecular
properties of elastin; elastin and microfibril assembly; role of elastin in regulating cell signaling; mechanosensing
of the elastin/microfibril-smooth muscle cell focal adhesions; aging of elastin-containing tissues; multi-omics and
other technologies for elastic fiber system analyses; genetic diseases caused by mutations in genes encoding
proteins in or associated with elastic fibers; bioengineering of elastic tissues; and translation of research to
improve treatment of diseases that disrupt elastin-containing tissues. The aims of the conference are the
following: Provide an inclusive environment and time for multidisciplinary and diverse scientists to gather and
interact to catalyze research and new collaborations in the elastin biology; Drive translational research and
breakthroughs in the diagnosis, management, and treatment of acquired and genetic disorders that involve
elastic fibers and microfibrils; Promote the early integration of young scientists from diverse backgrounds into
the elastin scientific community; Address issues related to rigor and reproducibility of data in the elastin biology
field; Provide information and interaction to drive diversity in elastin-related field and science in general. The
2023 Elastin, Elastic Fibers & Microfibrils Gordon Research Conference will focus on recent novel, unpublished
developments in the field and will stimulate discussions, collaborations, and novel hypotheses by participants
from diverse disciplines and backgrounds. The accompanying Gordon Research Seminar will provide the
trainees in the field a space to interact with established investigators, present their data, and learn new career
development skills.

Public health relevance
Project Narrative Elastin is an abundant matrix protein in the lungs, skin, arteries, and ligaments, and it performs the unique and critical function of providing elasticity to these organs. The 2023 Elastin, Elastic Fibers & Microfibrils Gordon Research Conference and Gordon Research Seminar will assemble the world's experts in the elastin field to learn and discuss recent developments in the field, establish collaboration to move the research forward, and mentor a diverse group of trainees for success in science.